Southern Illinois Bridges to the Baccalaureate

Abstract
The Southern Illinois Bridges to the Baccalaureate Program (SI Bridges) is a partnership among Southern
Illinois University Carbondale (SIUC), John A. Logan College (JALC) and Shawnee Community College (SCC)
that is designed to resolve some of the disparities in postsecondary education access and success in
biomedical and behavioral science (BBS) fields for students in our rural, economically and educationally
depressed region. SIU, a four-year research and teaching institution, has a long track record of providing
educational opportunities to diverse groups of students, and supporting undergraduate research and training in
BBS fields. All three institutions have inclusive excellence, access, and success as core values and provide
support services for the disadvantaged. The students served by the three partner institutions are largely poor
and hail from counties with high poverty, higher than average minority populations and low baccalaureate
degree attainment. SI Bridges will strengthen our on-going collaboration while providing institution-specific
improvements that will lead to research-rich environments and a solid foundation for SI Bridges students to
matriculate to SIU, graduate and enter careers or post-baccalaureate programs in BBS research. The program
will begin by informing students about career opportunities in BBS and infusing socially relevant and thought-
provoking learning activities into gatekeeper courses at the community colleges. Two cohorts of eighteen UR
students (8-10 each from the two participating community colleges) will be recruited to participate as Bridges
scholars. Bridges scholars will be in the program for two years. During the first year while at the community
college, they will engage in specialized classes to enhance academic and technical skills, personalized
mentoring, and professional development to bolster their success in baccalaureate education. After a Summer
Research Immersion, scholars will transfer to SIUC and enter faculty research labs where they will be
mentored for one year and integrated into the research enterprise. They will conduct an original, mentored,
research study in their field of interest during the summer between their junior and senior years. SI Bridges
support and experiences will increase the success of regional UR students in completing baccalaureate
degrees in biomedical disciplines by providing them with real research experiences in university laboratories
and courses to enhance their professional and academic success. Collectively, our program will increase both
the diversity and number of biomedical scientists supporting the mission of the NIH R25 mechanism.

Public health relevance
PROJECT NARRATIVE The Southern Illinois Bridges to Baccalaureate Program (SI Bridges) is an established, successful collaboration among three higher education institutions in Southern Illinois: Southern Illinois University Carbondale (SIUC), John A Logan Community College, and Shawnee Community College. The program provides the experiences and mentoring to enhance professional development, build confidence, and improve academic and research skills for underrepresented community college students from disadvantaged backgrounds (Bridges-eligible students) to complete the baccalaureate degree and join the workforce in biomedical and behavioral science (BBS) research. Two cohorts of 18 Bridges scholars will engage in the following four enrichment activities over the course of two years: research-enriched curricula at the community college, specialized skills courses at SIUC, a multifaceted support structure, and authentic research experiences mentored by SIUC faculty in BBS.